Technology Core: Metabolomics and Biochemistry

PROJECT SUMMARY (See instructions): Consistent with the stated objectives of this RFA, the goal of this technology core is to furnish a suite of biochemical tools, reagents and assays that will serve as the basis for generafing experimental evidence for the

Public health relevance
TB is the leading bacterial cause of deaths worldwide and a pathogen of pandemic proportion. However, like the case for most microbes, its most unique attributes, and potentially most selective targets, are encoded by genes of unknown function. The establishment of the metabolomic and biochemistry core proposed herein will help fill this gap in knowledge.